Validating novel sleep sensors and devices in older adults with Alzheimer's disease

Project Summary
Easily accessible, user friendly, and validated in-home sleep monitoring technologies
are in high research, commercial, and clinical demand for older adults. Monitoring
multiple physiological signals in patients’ homes provides a promising opportunity for
clinicians to improve treatment outcomes and conveniently access relevant health
metrics in older adults. Novel commercial and research grade devices are constantly
evolving to meet growing demand from consumers and increase accuracy. To improve
accuracy, more and more devices are integrating a wider array of physiological
processes (e.g., heart rate, SpO2, ECG). However, scientific validation studies
examining the accuracy and performance of these devices is minimal and completely
absent in older adults with common chronic conditions and in individuals with
Alzheimer’s disease and Alzheimer’s related dementias (AD/ADRD). Yet targeted
studies in these groups are necessary given aging- and AD-related changes in gait,
mobility, and physiological processes that may decrease the accuracy of devices.
This study seeks to validate sleep detection capabilities of commercially available
devices with physiological sensors in a diverse representative sample of older adults
with common chronic conditions and a group with AD/ADRD. Device performance will
be examined in in-home settings and compared to gold-standard sleep measures
(polysomnography – a montage of EEG, EMG, and EOG). Further, with a series of
questionnaires, we will identify high-utility device features, barriers to use, and other
aspects relevant to improving future device development and compliance in both
research and commercial settings. We consider this an essential first step towards
deploying devices for health and research.

Public health relevance
Project Narrative The proposed research seeks to characterize the validity of commercially-available and research-grade health-monitoring devices with advanced physiological sensing capabilities in older adults. We will target older individuals with common chronic conditions and individuals with AD/ADRD, as these populations are in the most need of portable health monitoring. These data are essential for the development of consumer and research grade devices with lower algorithmic bias, improved accuracy, and enhanced usability for clinicians and older adults.